Macrophages, Cell-Cell Communication, Ischemic Injury in Diabetes and the RAGE/DIAPH1 Signaling Axis

Project Summary: OVERALL
Ischemia, a complication of diabetic cardiovascular (CVD) and peripheral arterial disease (PAD), is accompanied
by the recruitment, infiltration and activation of monocytes/macrophages (MΦs), into affected tissues. In
diabetes, MΦ properties are perturbed and repair is significantly mitigated, leading to organ failure. The
microenvironments in the heart vs. the skeletal muscle display unique responses to ischemia, but the
mechanisms are not fully understood. The ligands of the receptor for advanced glycation endproducts (RAGE),
such as nonenzymatically glycated and oxidized advanced glycation endproducts; S100/calgranulins and high
mobility group box 1, which accumulate in non-diabetic and diabetic CVD and PAD tissue, and RAGE itself,
contribute to MΦ and niche-specific responses to ischemia. Mice globally devoid of Ager (the gene encoding
RAGE) or devoid of myeloid Ager (lethal irradiation/bone marrow transplantation) are protected from the adverse
effects of ligation of the left anterior descending coronary artery and the femoral artery, models for myocardial
infarction (MI) and hind limb ischemia (HLI), respectively. In MI and HLI models, Ager deletion is accompanied
by a marked reduction in tissue MΦ content and reduced expression of inflammatory mediators. Surprisingly, in
HLI, deletion of Ager is accompanied by increased MΦ content and expression of inflammatory mediators in the
skeletal muscle. Yet, in both cases, Ager deletion augured repair. Our discovery that the cytoplasmic domain of
RAGE interaction with the formin, DIAPH1, mediates signal transduction, generation of oxidative stress and
mitochondrial dysfunction (on account of our novel discovery that DIAPH1 binds to Mitofusin2 (MFN2) in
ischemic tissue MΦs, cardiomyocytes and endothelial cells), may hold the key to these RAGE-dependent
findings. The three Projects of this Program will use novel mouse models, state-of-the-art molecular biology
techniques, novel small molecule antagonists of RAGE-DIAPH1 interaction, NMR spectroscopy and in-cell
fluorescence assays to test the hypothesis that RAGE/DIAPH1 contributes to MΦ cell-intrinsic and MΦ-
cardiomyocyte cross talk in MI and to and MΦ-endothelial cell cross talk in HLI, thereby amplifying tissue
damage. We posit that RAGE-DIAPH1 and DIAPH1-MFN2 interactions control MΦ inflammation and that
pharmacological blockade of RAGE-DIAPH1-MFN2 interaction and/or administration of monocytes/MΦs devoid
of Ager or Diaph1 will facilitate the transition from pro-injury to adaptive MΦ inflammation and, thereby, hasten
tissue repair in the diabetic heart and peripheral arterial systems. The meticulous integration of in vivo biology
and molecular mechanisms studies (Projects 1 and 2) with structural biology (Project 3) assures the innovation,
significance and ultimate relevance of this work for the development of novel therapeutic strategies for diabetes
and ischemia.

Public health relevance
Project Narrative: OVERALL This Program Project will probe the mechanisms and identify new therapies for untoward monocyte and macrophage responses in ischemia, which, together with cellular perturbation in the microenvironment, amplify damage in myocardial infarction and peripheral arterial disease, especially in diabetes.